Encoding and modulation of vibration representations in human neocortex

PROJECT SUMMARY/ABSTRACT
Touch comprises an exquisite sensitivity to vibrations. This sensitivity underlies our ability to perceive
textures and sense through handheld tools. Much of the information conveyed by vibrations is carried in their
spectral content. Thus, vibration perception likely involves cortical processing that is analogous to the
processes that support hearing. Although the neural encoding of vibrations in the peripheral somatosensory
system is established, far less is known about vibration representations in the central nervous system. In this
project, we will extend on our investigations of the cortical basis of vibration processing and determine on how
vibration frequency representations are impacted by selective attention and compare the effects of spatial
attention and feature-based attention. This project is a supplement to a parent project that investigates intrinsic
and extrinsic factors which modulate cortical representations of vibration frequency.
Under this project, the Candidate will work toward 2 aims. Aim 1 is to characterize the effects of spatial
attention (attending toward or away from the stimulated hand) on vibration frequency representations. The
Candidate will implement a Bayesian decoding framework to quantify spatial attention effects and how these
may be modulated by changes in the positions of the hands in space. Aim 2 is to compare the effects of spatial
attention and feature-based attention (attending to a specific vibration frequency) using the Bayesian decoding
framework. This project will support the training of a diversity Candidate who is transitioning from working on
neurotechnology in her previous career stage to working on computational neuroimaging in her PhD training
stage. The training activities will facilitate the Candidate’s progress on 4 goals: 1) Become an expert in sensory
neurobiology, 2) Become an expert in the analytical tools used to study neuroscience, 3) Improve science
communication skills, 4) Improve in leadership and mentoring skills, specifically regarding diversity, equity, and
inclusion (DEI). The Candidate will also receive training in grant writing and lab management.
Successful completion of this project will provide the Candidate a strong foundation for a career in
computational neuroscience. The research goals achieved under this project would complement the goals
under the parent project to advance our understanding of how the human brain supports touch perception. Our
findings may inform the diagnosis and treatment of sensory, cognitive, and psychiatric disorders involving
somatosensory deficits, such as in individuals with brain damage, autism, schizophrenia, and age-related
cognitive impairments including Alzheimer’s disease.

Public health relevance
PROJECT NARRATIVE This project is aimed at understanding how the human brain encodes vibration information and how these representations are influenced by spatial attention and feature-based attention. This project provides support for a Candidate to be trained in computational neuroimaging and systems neuroscience. Completion of this project will enhance our understanding of how the human brain represents touch and prepare a promising Candidate for a career in computational neuroscience.